Molecular Physiology of Mitochondrial Calcium Transporters

Project Summary/Abstract
The mitochondrial Ca2+ transport system modulates mitochondrial Ca2+ levels to control important cellular
processes including ATP generation, cell-death pathways, and buffering of intracellular Ca2+ signals.
Malfunction of mitochondrial Ca2+ transport induces cardiac ischemia-reperfusion injury and neurodegeneration,
facilitates cancer metastasis, and provokes many other detrimental conditions in human disease. This system
includes three major players, the mitochondrial Ca2+ uniporter complex, the Na+/Ca2+ exchanger (mediated by
the NCLX protein), and the H+/Ca2+ exchanger (possibly mediated by Letm1). Although the mitochondrial Ca2+
uniporter has been studied extensively, the transport and regulatory mechanisms of the other two Ca2+
exchangers remain mostly unknown. These exchangers are important for physiology, because cardiac-specific
deletion of NCLX causes heart failure, and loss of a copy of LETM1 in humans induces epilepsy in the deadly
genetic disease Wolf-Hirschhorn syndrome. Here, we propose to study the fundamental mechanisms of these
mitochondrial Ca2+ exchangers and their contribution to mitochondrial Ca2+ homeostasis. In Aim 1, we will
determine the transmembrane topology and transport mechanisms of Letm1 using a wide range of methods,
including functional analysis of liposome-reconstituted proteins, substituted cysteine accessibility scan, single-
molecule photobleaching, and co-immunoprecipitation. Furthermore, we will employ new-generation CRISPR
prime-editor tools to test the hypothesis that Letm1 is the protein that mediates mitochondrial H+/Ca2+
exchange and that it can load Ca2+ into mitochondria under physiological conditions. In Aim 2, we developed a
novel procedure to purify human NCLX and reconstitute the protein in liposomes. This powerful tool will be
employed to establish the Na+/Ca2+ exchange stoichiometry, Michaelis-Menten kinetic parameters, and the
mechanisms underlying ion recognition. It will also allow us to determine how a small-molecule, membrane-
permeant compound CGP-37157 potently inhibits NCLX, thus providing useful information to further improve
this drug for potential clinical use. Completing the proposed work will fundamentally improve the scientific
knowledge of two mitochondrial Ca2+ transport proteins that play important roles in human pathophysiology,
and will pave the way for future endeavors to design new therapeutic strategies to treat debilitating diseases
caused by abnormal mitochondrial Ca2+ transport and homeostasis.

Public health relevance
Project Narrative The mitochondria Ca2+ transport system regulates crucial physiological functions, including cell ATP production, intracellular Ca2+ signaling, and cell fate determination. This project seeks to determine the transport properties and mechanisms of Letm1 and NCLX, two major players in the mitochondrial Ca2+ transport system. The results could provide key information to identify new medicines to treat cardiac and neurodegenerative diseases related to abnormal mitochondrial Ca2+ homeostasis.